Five-laser Aurora spectral flow cytometer

PROJECT SUMMARY
Flow cytometry is an essential tool for the single cell analysis of a wide variety of cell types to assess the
expression of surface and intracellular markers and perform functional measures. Conventional flow cytometry
has been unable to leverage the large variety of fluorochromes available for marker analysis, because the
technology is focused on a narrow window of their emission spectrum, in which many of these fluorochromes
overlap, limiting the number of markers that can be measured. In contrast, spectral flow cytometry acquires the
full emission spectrum of each fluorochromes, which enables high resolution characterization of fluorochromes
(or fluorescent proteins) that can be used in conjunction. Moreover, the autofluorescence emitted by unstained
cells can also be acquired and subtracted for better detection of weaker fluorescent signals.
The 5-laser Aurora from Cytek is one of the most powerful spectral flow cytometry instruments currently available
and the need for this technology is supported (1) by the fact that our two most high-end conventional flow
cytometers (LSRII) are reaching end of serviceable life in one year, and (2) by increasing demand for greater
capabilities, including more parameters analyzed per sample, as well as better sensitivity for dim markers and
for small particles. With the 5-laser Aurora, investigators can expand the number of markers assessed to well
beyond 30 markers: Cytek has validated a 40-color panel for human blood and Dr. Farber at the Columbia
University Irving Medical Center (CUIMC) is applying panels of 25-35 parameters for several of her projects with
several substitutions made possible by the flexibility of panel design. This capability is attractive to many Flow
Cytometry Core users who have limited amount of precious material to work with, including cells isolated from
small tissue biopsies, humanized mice (particularly blood and lymph node samples), patient airway washes and
tissue organoids. This technology is also ideal as an upgrade option for most of our LSRII users, as opposed to
mass cytometry, which requires acquiring or generating all new reagents. When testing the Aurora, users have
been able to overcome major roadblocks in their projects, such as the ability to identify tissues cells whose
autofluorescence was masking the expression of a fluorescent reporter. Users also validated the detection of
particles or cell products in the 100-200 nm size range, made possible by the Aurora's violet side scatter detector.
In this proposal, 34 principal investigators at CUIMC have indicated how their projects (84% of which are NIH-
funded) will be significantly enhanced by upgrading from conventional flow cytometry instrument to the 5-laser
Aurora. Thus, the addition of this instrument will have a beneficial and long-lasting impact on biomedical research
encompassing a broad variety of fields. Generous institutional support is provided in the form of incentives and
coverage of maintenance costs, and the operation of the 5-laser Aurora will be sustainable in the long-term
because its maintenance is comparable to conventional instruments in use.

Public health relevance
PROJECT NARRATIVE Spectral flow cytometers are the most advanced flow cytometry instruments for phenotypic and functional analysis of samples at a single cell level, capable of assessing 40+ markers (more than double the capacity of our “conventional” instruments), of subtracting autofluorescence to better reveal the expression of dim markers and of analyzing small particles with higher sensitivity. The Flow Cytometry core of the Columbia Center for Translational Immunology and the Herbert Irving Comprehensive Cancer Center is a well-established and well- managed facility, whose users are in increasing need for these capabilities to advance their projects. Thus, we are requesting funds to acquire a 5-laser Aurora spectral flow cytometer that will not only address those needs but also replace two old conventional flow cytometers that will be decommissioned in the near future.